Regulation of Cardiac Death and Energy Metabolism by MCL-1

? DESCRIPTION (provided by applicant): Cardiomyocyte-specific deletion of anti-apoptotic Mcl-1 results in a fatal cardiomyopathy preceded by loss of cardiac contractility, abnormal mitochondrial ultrastructure, and impaired respiration. Co-deletion of the pro- apoptotic effectors Bax and Bak rescued the lethality and impaired cardiac function induced by Mcl-1-deletion; however, mitochondria from Mcl-1, Bax, and Bak-deficient (TKO) hearts still exhibited ultra-structural abnormalities and deficient mitochondrial respiration. These data suggest that MCL-1 facilitates normal mitochondrial function and promotes cardiomyocyte survival in cardiomyocytes. We have identified that MCL-1 resides in distinct mitochondrial localizations exhibiting separable functions: outer mitochondrial membrane (OMM)-localized MCL-1 inhibits cell death and matrix-localized MCL-1 promotes normal mitochondrial physiology. However, how these forms of MCL-1 contribute to regulating cardiomyocyte survival and mitochondrial function remains unclear. Our central hypothesis is that in cardiomyocytes MCL-1 functions at separable mitochondrial localizations: the outer membrane form prevents apoptosis and the matrix-localized form maintains efficient cardiomyocyte mitochondrial function by supporting energy metabolism. We propose to use biochemical and genetic approaches to tackle the following significant and innovative questions: Aim 1: How does MCL-1 regulate the death of cardiomyocytes? Inducible deletion of Mcl-1 in adult hearts leads to the loss of cardiomyocytes and fibrosis. Our working hypothesis is that OMM-localized MCL-1 is required to promote cardiomyocyte survival by preventing BAX/BAK-mediated apoptosis. Aim 2: How do MCL- 1's different localizations contribute to regulating mitochondrial function in cardiomyocytes? MCL-1 loss leads to mitochondrial dysfunction even when Bax and Bak are deleted and causes defective fatty acid (FA) oxidation in model cell lines. We postulate that in cardiomyocytes matrix-localized MCL-1 facilitates normal mitochondrial FA oxidation. Aim 3. Can ectopic MCL-1 expression inhibit cardiac failure by preventing death and maintaining normal cardiomyocyte energy metabolism? In the advanced stages of heart failure myocardial energy metabolism shifts from primarily FA oxidation to increased glycolysis and there is evidence of cardiomyocyte death. Since, MCL-1 blocks both cell death and modulates cardiomyocyte mitochondrial function, we hypothesize that overexpression of MCL-1 targeted mutants will reveal that MCL-1 not only blocks cardiomyocyte death, but helps maintain cardiomyocyte energy metabolism. We are ideally positioned to carry out the proposed studies as we possess expertise in studying MCL-1's diverse functions in vitro and in vivo, have developed essential mouse genetic models to support the studies, and are experienced in characterizing MCL-1's role in cardiac function. At the end of this study, we will have a new understanding of how MCL-1's diverse functions may be utilized to promote cardiomyocyte survival and may reveal ways to avoid potential cardiac toxicities associated with chemotherapeutic inhibition of MCL-1.

Public health relevance
PUBLIC HEALTH RELEVANCE: Heart failure is a prominent cause of morbidity and mortality in the United States that is typified by increased cardiomyocyte death and altered cardiomyocyte energy metabolism. Cardiomyocyte-specific deletion of MCL- 1, an essential anti-apoptotic BCL-2 family member, results in cardiomyocyte loss and defective mitochondrial function; therefore, it is important to mechanistically interrogate how MCL-1 regulates these processes in vivo. This proposal is relevant to the goals of the National Institutes of Health because it will determine how MCL-1 promotes cardiomyocyte function and survival with the goal of identifying new therapeutic strategies for preventing heart failure.